DEVELOPMENT OF TECHNIQUES FOR IMPROVED MAD PHASING: RAPID STRUCTURE SOLVING

We plan to develop methods that will extend the applicability of the multiwavelength anomalous diffraction (MAD) method to structures with as many as 50 anomalous scattering atoms. These methods will be highly automated and will enable the steps between MAD data collection and map calculation to be accomplished without human intervention. The approaches will be tested and developed at beamline X1 2C at the NSLS by setting up procedures for automated structure determination that users can follow as soon as they collect their x-ray diffraction data.